Studying metabolic stress signaling in renal cancer

Project Summary
Renal cell carcinoma (RCC) is a major metabolic cancer, and several well-known renal cancer genes are
involved in pathways that respond to metabolic stress. Thus, there is a critical need to understand the metabolic
stress pathways involved in RCC development and to develop treatments that target the fundamental metabolic
vulnerabilities in RCC. BAP1 acts as a tumor suppressor gene in RCC, with inactivating mutations in up to 15%
of cases and frequent deletion in clear cell RCCs (ccRCCs), and patients with BAP1-mutant ccRCC exhibit
particularly poor clinical outcomes. However, how BAP1 functions as a tumor suppressor in renal cancer remains
unclear, and currently there is no effective therapy to treat RCC patients with BAP1 mutations. BAP1 and its
associated proteins form the polycomb repressive deubiquitinase (PR-DUB) complex, which reduces histone 2A
ubiquitination (H2Aub) on chromatin and regulates gene transcription. SLC7A11 is a cystine transporter. Our
recent publications and preliminary data link BAP1 to SLC7A11 and support the central hypotheses of our
proposal that (i) the BAP1-containing PR-DUB complex mediates H2Aub de-ubiquitination and transcriptional
repression of SLC7A11, and BAP1 deficiency or alteration of other components in the PR-DUB complex de-
represses SLC7A11 expression, rendering renal cancer cells more resistant to ferroptosis (a non-apoptotic cell
death induced by metabolic stress) and contributing to RCC development; and (ii) BAP1-deficient/mutant renal
tumors are more dependent on glucose for survival, partly due to high SLC7A11 expression in these tumors,
thus exposing a metabolic vulnerability for therapeutic targeting. In this proposal, we will employ multi-disciplinary
approaches to test our hypotheses. The rationale for the proposed research is that studying the roles of the
BAP1-SLC7A11 signaling axis in ferroptosis and glucose dependency will not only advance our understanding
of how renal cancer cells bypass ferroptotic cell death to survive and grow but also provide important insights
into the development of novel therapeutic strategies to target accompanying metabolic vulnerabilities in RCC.
With respect to expected outcomes, our proposed studies will identify novel regulatory mechanisms of ferroptosis
pathways, clarify the tumor suppression function of BAP1, and identify new effective therapies to target metabolic
vulnerabilities in renal cancer. Our proposal is highly innovative because it focuses on a previously unexplored
pathway to link metabolic stress signaling to tumor development and treatment. Our proposed studies will have
significant impact on both our understanding of the fundamental mechanisms of metabolic stress response and
our ability to target nutrient dependency in renal cancer treatment.

Public health relevance
Project Narrative There is a critical need to understand the metabolic stress pathways involved in renal cell carcinoma (RCC) development and to develop treatments that target the fundamental metabolic vulnerabilities in RCC. The objective of this application is to study the roles and mechanisms of the RCC tumor suppressor BAP1 in the regulation of ferroptosis and glucose dependency, and the relevance of this regulation to renal tumor development and treatment. Our proposed studies will have significant impact on both our understanding of the fundamental mechanisms of metabolic stress response and our ability to target nutrient dependency in renal cancer treatment.